Role of T Regulatory Cell Suppression in Autoimmunity and Cancer

Our studies of Tregs have revealed that TNF by acting on the TNFR2 receptor, which is most highly expressed by Tregs, unexpectedly results in the proliferative expansion and functional activation of Tregs both in mice and in man. In view of the well-known proinflammatory effects of TNF, our data showing that TNF in a more delayed manner can also down-regulate immune responses, is rather surprising. Furthermore, TNF together with IL-2 up-regulates the cell surface expression of TNFR2 and also of 4-1BB and OX-40 receptors on Tregs. Thus, TNF amplifies its stimulatory effect on Tregs by inducing at least 3 TNFRSF receptor family members. TNF interactions with TNFR2 also stabilizes the CD4+FOXP3+ T regulatory cell phenotype at inflammatory sites. One clarification of these unexpected effects of TNF is based on our data showing that TNF by activating T effector cells also induce them to express more TNFR2 and to become more resistant to the suppressive effects of Tregs. Thus, activated inflammatory cells can prevail over the suppressive effects of Tregs. However, as inflammation subsides in healing wounds or in non-inflamed tumors, Tregs prevail. About 50% tumor infiltrating T cells (TIL's) develop into Tregs and express TNFR2. They are activated by tumor-derived TNF to be even more immunosuppressive than Tregs in peripheral lymphoid tissues. Suppression of Tregs results in more effective host antitumor responses and reduces tumor growth. We hypothesize that TNFR2 can be targeted as a functional immune checkpoint. This hypothesis was tested by treating mice bearing small CT26 colon tumors with neutralizing anti-TNFR2 antibodies, which suppresses Tregs, and enables CpG, a TLR9 ligand, to promote cell mediated immunity. This resulted in 80% of the mice becoming tumor free and selectively resisting a subsequent CT26 tumor challenge. These treated mice developed considerable infiltration of their tumors by IFNgamma producing rather than Treg TIL cells and since MDSC also express TNFR2, it reduced the numbers of immunosuppressive MDSC in their spleens and tumors. These finding suggest that this therapy enabled the mice to exhibit considerable antitumor immunity. In collaboration with Prof. Xin Chen's Laboratory at University of Macau, we have recently demonstrated that anither TNFR2-inhibiting antibody can replace anti-PD-L1 in TheraVac to mount efficient antitumor immunotherapy in mice, further consolidating the notion that TNFR2 potentially acts as one functional immune checkpoint for antitumor immunity. Identification of more potent antagonists of TNFR2 should yield even more effective checkpoint inhibition. This idea motivated us to collaborate with Dr. Dimiter Dimitrov and his colleagues who engineered the production of high affinity anti-human anti-TNFR2 antibodies. These antibodies are specifically cytotoxic by ADCC for human, but not mouse cells expressing TNFR2. The antibody may be able to deplete both highly activated human Tregs and Teff cells. Aside from its ADCC activity against human Tregs in vitro, we have recently revealed that application of this antibody into human PBMC-humanized nude mice results in the reduction of TNFR2-positive CD4 T cells in peripheral blood, affirming that it also has in vivo ADCC effect on human Tregs. We therefore have to collaborate with a clinical group that would be interested in testing this humanized anti-hTNFR2 antobody in patients to determine if it acts as a potent checkpoint-like inhibitor of Tregs to promote anticancer immunity in human cancer patients. Although a number of companies have expressed an interest, none have licensed this antibody as yet. Our investigating of the mechanism of action of activation of TNFR2 has revealed that the membrane associated TNF ligand (mTNF) acts as an inhibitor of two-pore channels (TPC) in DC. Our collaborators in China led by Dr. Xin Chen have identified a Traditional Chinese Medicine (TCM), tetradrine, which also inhibits TPC. Tetradrine was shown to attenuate inflammation of the colon by expanding Tregs. This was shown to be due to inhibition of TNF converting enzyme which increases the levels of mTNF that in tumor TNFR2 expressing immunosuppressive Tregs. Overall, these results indicate that stimulation of this pathway promotes anti-inflammatory Tregs. Overall, these results indicate that stimulation of this pathway promotes anti-inflammatory Treg activities and tetratrine could be of preferential therapeutic benefit for autoimmune conditions.